Determining how Doublesex and sex-specific steroid hormone signaling control gonad development

PROJECT SUMMARY
In the animal kingdom, sexual dimorphism, or phenotypic differences between the sexes, is seen in most
species. In Drosophila, the key factor controlling sexual dimorphism is Doublesex (Dsx), the founding member
of the conserved Doublesex/Mab-3 Related Transcription Factor (DMRT) family. DMRTs have central roles in
sex determination across many species including flies, humans, and mice. Although few Dsx targets have
been characterized, our lab has shown that Dsx regulates sex-specific steroid hormone Ecdysone (E) signaling
through female-specific Ecdysone Receptor (EcR) expression, and that this functions to promote ovary
development and repress testis development at a key developmental timepoint. Bioinformatic analyses has
been used to predict Dsx targets, and many of these are transcription factors that contain a Broad-complex,
tramtrack, and bric-a-brac (BTB) domain, a protein-protein interaction motif. To identify Dsx targets that play a
role in sexual dimorphism of the gonad, I performed a reverse screen of BTB domain proteins containing
putative Dsx binding motifs using RNA interference. As a result, I found that loss of mamo in somatic cells of
the gonad led to severely disorganized ovaries and, in some cases, the formation of rudimentary testes in XX
animals. Given these findings, I hypothesize that mamo is critical for proper development in the
Drosophila ovary, and that it functions downstream of Dsx and E signaling to help establish a female
sexual fate. This hypothesis will be addressed by first examining the cell-type-specific expression of Mamo
throughout development and performing genetic interaction assays with dsx. I will characterize what cell types
are affected in the absence of mamo using cell-specific markers and ascertain whether loss of mamo results in
sex transformation properties of the ovary. A second BTB domain protein, Chinmo, has been shown to be
important in the testis, and the relationship between mamo and chinmo, and how E signaling regulates these
factors, will be determined. This work will expand current knowledge on how DMRTs control sexual
dimorphism and could uncover genes critical for sexual identity in both flies and mammals. Due to the
universal nature of DMRTs in controlling sex-specific development, understanding their targets and how they
function is of great importance for reproductive health and has the potential to broaden our knowledge of
human infertility.

Public health relevance
PROJECT NARRATIVE The process of sex determination has significant consequences on animal development and results in distinct differences in organ systems, behavior, and even responses to diseases. Animals like humans and flies use conserved mechanisms, such as the Doublesex/Mab3 Related Transcription Factors (DMRTs) and steroid hormone signaling, to regulate sexual development in the gonad. Elucidating these mechanisms is critical for understanding how sexual development occurs and can further treatment of human syndromes leading to Differences of Sexual Development and infertility.